Gutierrez, Susan Diversity Supplement

PROJECT SUMMARY/ABSTRACT
This application is for 8th consecutive renewal of the Ruth L. Kirschstein National Research Service Award T32
Postdoctoral Research “Training Program in Pediatric Gastroenterology/Nutrition” at the University of
California, San Francisco (UCSF). More than 70% of graduates of UCSF Training Program in Pediatric
Gastroenterology/Nutrition remain productive researchers and academic leaders in their respective fields The
Program aims to train talented and dedicated young physicians to become independent and productive
scientific investigators, and recent graduates have been successful in progressing along academic career
development pathways. These future scientists will research important health problems, focusing on the
causes, pathogenesis, and treatment of digestive, liver and nutritional disorders in infants and children.
Preference is given to trainees committed to a 4-year training program, including 3 years of research training in
either Basic (T1 track) or Clinical/Translational (T2 track) Research mentored by established scientists. The
key elements of the proposed training are: (1) a mentored research experience, (2) scientific course work, (3)
career development workshops, (4) interdisciplinary experiences and (5) ongoing review and evaluation. Basic
research experience is supplemented with coursework, seminars, and inter-departmental retreats; trainees in
clinical research participate in the well-established Training in Clinical Research Program that includes a 1-
year Advanced Training in Clinical Research certificate, leading to a 2-year Master’s Degree in Clinical
Research program. Each trainee pursues an obligatory research project(s) supervised by experienced
preceptors. All trainees take courses in Responsible Conduct in Research, Research Rigor and
Reproducibility, Scientific Writing and the Art of Lecturing. The trainee and research mentor determine
additional course work in the specific field of research. Entry requirements include a MD degree and 3 years of
residency in clinical pediatrics. Applicants with a PhD degree and defined career goals related to
developmental gastroenterology or nutrition are also eligible. Administration of the program is restructured to
take advantage of the strengthened Division of Pediatric Gastroenterology/Nutrition under the primary direction
of Dr. Melvin Heyman, associate direction from Dr. Philip Rosenthal, and mentored assistant direction from
Drs. James Bayrer and Emily Perito. The quality of educational and research programs and activities are
closely monitored by trainee mentors, research preceptors, Internal Advisors, the Assistant Program Directors,
the Associate Program Director, the Program Director, and annual evaluations by distinguished External
Advisors. An increase from 3 to 5 training positions is requested in Years 41-45.

Public health relevance
PROJECT NARRATIVE This Program is directly relevant to child health and development in training the next generation of scientists who will generate the advances essential for improving the quality of life and survival rates of children and adolescents with gastrointestinal, liver and nutrition-related disorders. Further, this training program represents an investment in the future of public health in general, as the multidisciplinary, intensive and innovative training provided by this Program will educate the leaders, teachers, and professional role models who will determine the direction and contributions of American medicine domestically and throughout the world, particularly as relates to pediatric gastroenterology, hepatology and nutrition.